Saliva Anti-SSA/Ro and Anti-SSB/La for Early Detection of Sjögren’s and SICCA Syndromes

Project Summary/Abstract:
Early detection of Sjögren’s Disease (SjD) and its precursor autoimmune-Sicca Syndrome (AI-
Sicca), are unmet clinical needs. Serum anti-Ro/SSA autoantibodies and biopsy focus score are
two key classification criteria of SjD by the 2016 ACR-EULAR 1. SjD is a complex disease. Clinicians
provide symptomatic treatment to patients as the symptoms of SjD are similar to other physiological
and pathological changes in the body including menopause, drug side effects and fibromyalgia
amongst others. This leads to a 3-year delay in initial diagnosis from the time the patients first seek
medical care. In addition, there is currently no test for the diagnosis of AI-Sicca.
In order to address this unmet clinical need, we have developed a saliva-based electrochemical
assay, electric field-induced release and measurement (EFIRM), that can screen, earlier detect and
risk assess onset of SjD, alternative to the current ELISA blood-based serology assay. Preliminary
data demonstrated: 1) EFIRM can directly detect and quantify salivary anti-SSA/Ro52
autoantibodies in SjD patients; 2) Salivary and serum anti-SSA/Ro52 are correlated in SjD and AI-
Sicca patients; 3) Salivary anti-Ro52/SSA IgA1 correlate to salivary gland focus scores. This R21
application will test the hypothesis in a large cohort of SjD and AI-Sicca patients that EFIRM, can:
1) detect anti-SSA/Ro52 and anti-SSB/La in saliva of SjD and AI-Sicca patients, and 2) salivary
IgA1 to SSA/Ro52 is associated with salivary gland tissue destruction as measured by focus scores.
Furthermore, monomeric versus polymeric forms for IgA1 to salivary SSA/Ro52 can discriminate
SjD from AI-Sicca patients. Should this hypothesis be validated, the EFIRM salivary anti-SSA/Ro52
and anti-SSB/La assays can be explored for early detection of SjD and AI-Sicca in prospective
multi-site clinical study as well as basic science mechanistic pursuits. In addition, saliva monitoring
of IgA1 to SSA/Ro52 can be hypothesis tested for monitoring AI-Sicca progression to SjD in a non-
invasive sample type (saliva).
Three specific aims are proposed for this project. Specific Aim1: Acquire and Characterize Clinical
cohorts of SjD, AI-Sicca and matched control subjects. Specific Aim 2: EFIRM quantitative
assessment of anti-SSA/Ro52 and anti-SSB/La in saliva of SjD, AI-Sicca and Controls. EFIRM
SSA/Ro52 and SSB/La autoantibody immunoassays will be performed on 210 SjD, 210 AI-Sicca
and 315 controls subjects (blinded and randomized). Hypothesis testing of saliva SSA/Ro52 and
SSB/La autoantibodies to discriminate 1) SjD vs AI-Sicca; 2) SjD vs Controls; 3) AI-Sicca vs
Controls and 4) (SjD + AI-Sicca) vs Controls. Specific Aim 3: Quantification of monomeric and
polymeric anti-SSA/Ro52 IgA1 in saliva of SjD and AI-Sicca patients.

Public health relevance
Project Narrative There is no early detection for Sjögren’s Disease (SjD) and its precursor autoimmune AI-Sicca. We have developed an electrochemical assay, EFIRM, that can measure the diagnostic autoantibodies of SjD, SSA/Ro52 and SSB/La. We hypothesize that IgA to these autoantibodies, can early detect and predict AI-Sicca from SjD.